The benefits of nicotinamide riboside upon cognition and sleep in older Veterans

Project summary/ abstract
Candidate: My overarching goal is to promote healthy aging through quality sleep as an independent
nurse-scientist. My clinical training in geriatrics and behavioral sleep medicine and my pre-clinical
fellowship in sleep and circadian disruptions lay the foundation for my expertise to reach this goal. This
proposal will permit training in basic sciences applied to human studies to support the understanding of
molecular mechanisms of poor sleep and cognitive impairment in older adults and their underlying
interactions. The career development proposed in this application will empower my growth as an
emerging leader from an underrepresented background with previous awards from the Sleep Research
Society and American Academy of Sleep Medicine.
Mentors and Environment: A prominent team of mentors and consultants has been assembled for this
project composed of Dr. Rebecca Lorenz (Primary Mentor, Nursing, Geriatric, Sleep), Dr. Brienne Miner,
(Geriatrics, Sleep), and Dr. M. Jeffery Mador (Sleep, Veteran Healthcare). We have created a training
program to nurture research and leadership skills based upon the University at Buffalo and Yale
University programs on geriatrics and sleep research for successful execution of the career development
and research project outlined in this application.
Mentored Research Project: Poor sleep quality and short sleep duration are associated with cognitive
impairment in older adults and may be candidate mechanism underlying Alzheimer’s Disease and other
dementias via impaired mitochondrial function and/or a reduced expression of brain-derived neurotrophic
factor (BDNF). Our previous work indicated that enhancing the availability of nicotinamide adenine
dinucleotide (NAD+) improves physical performance and cognition in aged mice and may reduce
cognitive decline and support sleep quality by boosting mitochondrial function and enhancing BDNF
expression. We propose a randomized clinical trial investigating the effects of supplementation with the
NAD+ precursor, nicotinamide riboside, a form of vitamin B3, on sleep quality, objective sleep duration,
and cognition in older adults. To accomplish these goals, we will assess sleep quality, objective sleep
and cognitive function, as well as examine serum levels of BDNF of participants who receive a three-
month supplementation with NR or placebo. This proposal will confirm the potential of NR as a low-risk
and low-cost intervention for both healthy sleep and optimized cognitive function.

Public health relevance
Project Narrative Poor sleep quality and short sleep duration may be a mechanistic component of cognitive impairment in older adults, associated with a decline in brain-derived neurotrophic factor. Increasing the availability of nicotinamide adenine dinucleotide (NAD+) with supplementation of its precursor, nicotinamide riboside (NR), may increase the expression of brain-derived neurotrophic factor. We propose to examine the benefits of NR supplementation upon sleep and cognitive function in older adults with comprehensive subjective and objective measures and to explore its impacts on serum brain-derived neurotrophic factor. Project Narrative